AMC 005--CHOP &TRIPLE ANTIRETROVIRAL IN AIDS RELATED NON HODGKINS

This pilot study aims to evaluate the safety & toxicity & tolerance of combination cyclophosphamide, doxorubicin, vincristine, and prednisone (modified-chop) in combination w/triple antiretroviral therapy consisting of the protease inhibitor indinavir and 2 anti-retroviral transcriptase agents, 3tc and 4d4t.